Promoting Utilization and Safety of Hydroxyurea Using Precision in Africa

Project Summary/Abstract
Sickle cell anemia (SCA) is among the world’s most common and devastating blood disorders, affecting more
than 300,000 newborns per year. The majority of infants with SCA are born in the low-resource settings of sub-
Saharan Africa, where an estimated 50-90% will die before 5 years of age due to lack of early diagnosis and
appropriate care. Hydroxyurea is a once-daily oral medication that has become the standard of care for the
treatment of children with SCA in high-resource settings. There is now a growing body of evidence to support
the safety and clinical benefits of hydroxyurea for the treatment of SCA in sub-Saharan Africa. The requirement
for frequent laboratory monitoring and the concern for hematologic laboratory toxicities, however, will limit
widespread hydroxyurea utilization. We have recently developed and prospectively evaluated an individualized,
pharmacokinetics-guided hydroxyurea dosing strategy for children with SCA that has demonstrated optimal
clinical and laboratory benefits with minimal toxicity. In this proposal, we aim to extend this precision medicine
approach to Africa. This proposal includes a prospective, randomized clinical trial of hydroxyurea for children
with SCA at two clinical sites in sub-Saharan African (Luanda, Angola and Mwanza, Tanzania). The study will
be the first to bring precision medicine to children with SCA through several novel features including
measurement of hydroxyurea using a battery-powered HPLC machine and individualized dose calculations using
an automated computer-based algorithm. The first phase of the study will compare dosing strategies and
determine the optimal dosing strategy, and the second phase will importantly address the safety of hydroxyurea
therapy with limited laboratory monitoring. The primary objectives are to establish the feasibility and evaluate the
clinical benefits of PK-guided hydroxyurea for children with SCA in Africa and to provide evidence to support
minimal laboratory monitoring with hydroxyurea therapy in these settings. We will accomplish these objectives
through the following Specific Aims: Specific Aim 1: To compare the clinical benefits of two hydroxyurea dosing
strategies for treatment of SCA in sub-Saharan Africa: a novel individualized, PK-guided initial dose without
subsequent escalation and a weight-based dose with subsequent dose escalation. We hypothesize that the PK-
guided arm will have a reduction in sickle-related adverse events compared to the weight-based arm. Specific
Aim 2: To evaluate the safety of hydroxyurea for children with SCA in sub-Saharan Africa with limited laboratory
monitoring. We hypothesize that there will be no difference in the frequency of adverse events (Grade ≥ 3)
unrelated to SCA during the period of hydroxyurea treatment with limited monitoring compared to the no
treatment run-in period. Exploratory Aim 3: To evaluate the utility and validity of two established measures of
health-related quality of life (HRQoL) for patients and families affected by SCA in Angola and Tanzania before
and after hydroxyurea treatment. We hypothesize that baseline HRQoL measures will be low for both measures
and will improve significantly with hydroxyurea treatment.

Public health relevance
Project Narrative Sickle cell anemia is an inherited blood disorder that affects millions of children across the world, mostly in sub- Saharan Africa, who will suffer from serious complications, including death, if treatment is not available. Hydroxyurea, a once daily oral medication has been shown to improve most symptoms and reduce mortality for children and adults with sickle cell anemia but is rarely used in many limited-resource settings due in part to concerns about appropriate dosing and monitoring. The primary objectives of this research study are to establish the feasibility and evaluate the clinical benefits of personalized hydroxyurea dosing and to evaluate the safety of hydroxyurea use with limited laboratory monitoring for children with sickle cell anemia living in Angola and Tanzania to provide evidence that will allow for expanded access to this lifesaving medication.